Endothelial Mechanotaxis During Development

? DESCRIPTION (provided by applicant): Formation of blood vasculature is a complicated process requiring both genetic and environmental input. Failure in vascular development is a major cause of congenital birth diseases. The most important environmental factor controlling vascular remodeling is blood flow which has an ability to change the identity of vessels, and critical in regulation of formations of interconnections between the primary network and secondary sprouts. Understanding the mechanism by which vasculature adapts to changes in blood flow perfusion is of critical scientific and clinical importance. Endothelial cells form the interface between blood and underlying tissues, and are usually thought of as motionless unless there is tissue injury or angiogenesis. However, I made a novel and unexpected finding that endothelial cells migrate centrifugally in venous circulation, a process that is likely to influenc vascular patterning. Moreover, I have developed new microfluidic devices that allow me to study endothelial cells under a wide variety of flow conditions. I propose to investigate mechanosensing mechanisms by which flow directs endothelial cell migration and to determine the role of this migration in vascular development.

Public health relevance
PUBLIC HEALTH RELEVANCE: Blood flow is the main regulator of vascular remodeling, and failure in vascular remodeling is a major cause of congenital anomalies. Endothelial cells outline inner surface of blood vessels and sense changes in blood flow perfusion. I propose to investigate the mechanism by which blood flow controls migration of endothelial cell and the role of this migration in vascular remodeling.